Biogenesis and Catabolism of Atherogenic Lipoproteins

SUMMARY/ABSTRACT – OVERALL: More people die of cardiovascular disease (CVD) than any
other disease worldwide. Our proposal focuses on the biogenesis and catabolism of atherogenic apoB-
containing lipoproteins (apoB-Lps), which are major risk factors for CVD. ApoB-Lps comprise both cholesterol
and triglycerides (TGs). Whereas reducing cholesterol is well established to reduce atherosclerosis, it remains
to be convincingly determined whether decreasing levels of TGs or the apoB-Lps that carry TGs will decrease
CVD. Blocking secretion of apoB-Lps by the liver reduces levels of cholesterol-rich apoB-Lps, such as LDL and
its TG-rich precursor VLDL. Unfortunately, such approaches have led to hepatosteatosis. However, human
genetic mutation and animal studies demonstrate that reduced liver secretion of TGs does not invariably cause
steatosis. By characterizing novel factors and pathways regulating liver apoB-Lp production, intravascular
lipolysis, and adipose TG retention and mobilization, we will identify unique targets to reduce circulating apoB-
Lps, their infiltration into the artery wall, and atherosclerosis. We will define basic mechanisms in cells and in
new rodent models and then correlate our discoveries with human data, emphasizing a translational and
transfomative approach. Our overall goals are to: 1) identify new processes and factors regulating circulating TG
and FA levels, 2) investigate the lipidation and intracellular transport of apoB in hepatocytes, and 3) study how
different apoB-Lps interact with cells and ultimately catalyze atherogenesis. This application comprises three
projects (P1–P3) that have integrated work from three established investigators of apoB-Lp metabolism and
atherosclerosis. P1 will investigate the role of adipose MTP and FIT2 in regulating adipose lipolysis, circulating
lipids, hepatic apoB-Lp production, and atherosclerosis. P2 will study two poorly characterized proteins in the
liver, KLHL12 and FIT2, which control hepatic apoB-Lp lipid-loading and secretion, and the composition of
atherogenic apoB-Lps. P3 will study how TG-rich apoB-Lps interact with the vascular wall, and specifically
determine the role of the N-terminal region of apoB on lipid uptake and transcytosis of apoB-Lps by vascular
ECs and their links to atherosclerosis. The PPG has an administrative core and three scientific cores (C1–C3).
The Administrative Core will oversee the overall PPG function and finances. To assist P1–P3, C1 will provide
biostatistics and bioinformatics support, C2 will perform lipidomics and proteomics on apoB-Lps and tissues and
provide human samples, and C3 will perform state-of-the-art atherosclerosis assays. Our studies will generate
novel mouse models invaluable to understand the factors that regulate lipid metabolism and atherosclerosis,
identify new therapeutic targets, and better define how high circulating levels of atherogenic apoB-Lps and other
factors contribute to atherogenesis. Dissecting pathways that regulate the production and atherogenicity of apoB-
Lps promises to reveal novel approaches to reduce CVD. This requires the integration of reseach in our three
projects, as experiments in each require assistance from the others and core resources.

Public health relevance
NARRATIVE – OVERALL: ApoB-containing atherogenic lipoproteins are the primary cause of atherosclerotic cardiovascular disease. We propose to understand the roles of liver, adipose tissue, and vascular endothelail cells in producing these atherogenic lipoproteins, a coordinated effort that will uncover novel targets, treatments, pathways, and mechanisms useful for future personalized therapies to reduce the risk of atherosclerosis.